Antibody Drug Conjugate Designs to Enhance the Therapeutic Window for Brain Tumors

PROJECT DESCRIPTION/ABSTRACT
Glioblastoma, IDH-wildtype (GBM) is the most common and most lethal primary brain cancer. Despite
tremendous research efforts, the last FDA drug approval for newly diagnosed GBM was temozolomide in 2005,
and these tumors invariably recur with a median survival of only 16 months. Thus, there is a tremendous
unmet medical need to develop effective therapies for this disease. Antibody drug conjugates (ADCs) are a
rapidly growing class of molecularly targeted therapeutics with impressive clinical activity in various solid
malignancies. ADCs capitalize on tumor-specific monoclonal antibodies to deliver highly potent toxins into
tumor cells, while limiting exposure to normal tissues. Given this potential for selective tumor therapy, we have
been investigating the potential of ADCs in GBM for over five years. GBM express a number of tumor antigens
for which ADCs have been developed including Epidermal Growth Factor Receptor (EGFR) and B7 family of
immune-regulatory checkpoint protein (B7H3). In partnership with AbbVie, members of our team evaluated
three EGFR-targeted ADCs in a panel of GBM patient-derived xenografts (PDXs). These studies demonstrated
that i) most EGFR-amplified GBM grown as heterotopic tumors are profoundly sensitive to these ADCs, ii)
restricted delivery across the blood-tumor barrier after systemic dosing limits the efficacy of the same ADCs in
most orthotopic PDXs, iii) direct infusion of ADCs into brain tumors using convection enhanced delivery (CED)
can be highly efficacious, and iv) neuronal toxicity of ADCs delivered into the brain is highly dependent on
stability of the linker. These key findings provide the overall rationale for this R01 that is focused on
engineering ADCs specifically designed to enhance the therapeutic window for treatment of GBM and other
cancers within the central nervous system. Importantly, the work proposed is only possible with the collective
expertise of our key team members: Dr. Kyoji Tsuchikama (MPI) is a medicinal chemist and leader in ADC
engineering, Dr. Jann Sarkaria (MPI) is an expert in translational development of novel therapeutic strategies
for GBM, and Dr. William Elmquist (Co-I) is a world-leader in the pharmacokinetics of drug distribution in the
central nervous system. With this team, we will address key challenges in the development of ADCs as a
therapy for GBM in three specific Aims.
Aim 1: Develop novel linker chemistries to improve stability of ADCs in the brain
Aim 2: Evaluate the potential to limit neuronal toxicity through optimized toxin selection
Aim 3: Evaluate novel ADC therapeutic strategies to address tumor heterogeneity

Public health relevance
PUBLIC HEALTH RELEVANCE Antibody drug conjugates (ADCs) are highly effective drugs for a variety of solid tumors, but they have not yet been useful for brain tumor patients. Our laboratories have shown that ADCs can be highly effective against brain tumors, but toxicity to neurons can be a problem. The goal of this study is to design more effective ADCs with better safety profiles in the brain for the treatment of brain tumors.